SAFETY AND EFFICACY OF RHGH ALONE AND WITH ESTRADIOL IN PATIENTS

To demonstrate the safety and efficacy of methionine-free human growth hormone, recombinant human growth hormone(rhGH), alone and with low dose ethinyl estradiol in alleviating growth retardation associated with Turner's Syndrome and which combination would be the best treatment in the future.